Dissecting the role of IER3IP1 in neurogenesis and brain malformation

Project Summary
Primary microcephaly is a structural birth defect characterized by a significantly smaller head
circumference than the mean of age and gender at birth. It is mainly linked to dysfunction of the neural progenitor
cell population, resulting in reduced neurons in the cerebral cortex. Most microcephaly-causing genes are
involved in mitosis and cytokinesis; however, recently, defects in secretory protein trafficking have been
implicated in causing microcephaly. One of the newly identified genes that are potentially involved in protein
trafficking is IER3IP1. Bi-allelic variants of IER3IP1 have been reported to cause a rare, pediatric,
neurodevelopmental condition called microcephaly with simplified gyration, generalized epilepsy, and permanent
neonatal diabetes syndrome (MEDS). MEDS patients present with severe congenital structural brain
abnormalities, including microcephaly, ventriculomegaly, and cerebral atrophy. Prior studies on IER3IP1 suggest
that its function is involved in ER to the Golgi trafficking in humans. I confirmed that the pathogenic variant blocks
ER to Golgi trafficking with a GFP trafficking reporter, and the correction of IER3IP1 mutation through
CRISPR/Cas9 restored the trafficking efficiency. Herein, I propose to focus on elucidating the function of IER3IP1
in neurogenesis and human brain development to understand how faulty protein trafficking leads to brain birth
defects.
I hypothesize that IER3IP1 regulates secretory protein trafficking during neurogenesis. I have
successfully generated and characterized cortical brain organoids and 2D neuronal culture derived from MEDS
patient-derived induced pluripotent stem cells and isogenic control cells to test this. Using these MEDS patient
cell models, I will complete the following aims: Aim 1. What is the underlying cellular mechanism of microcephaly
seen in MEDS patients with IER3IP1 p.L78P mutation? and Aim 2. Does IER3IP1 regulate the molecular
trafficking of membrane receptors important in neurodevelopment? This proposal will fill the gap in our
understanding of how protein trafficking regulates neurogenesis and provide insight into how abnormal protein
trafficking leads to structural brain abnormalities.

Public health relevance
Project Narrative Secretory protein trafficking enables newly synthesized proteins to be transported to the cell surface. Faulty trafficking is implicated in developmental defects in brain development; however, how defective trafficking causes abnormal brain development is unknown. This work aims to elucidate how inefficient protein trafficking leads to brain birth defects and abnormal neuronal differentiation using rare disease patient-derived cell models.